Physiological, Behavioral and Predictive Correlates of Ototoxicity in Humans

Ototoxicity is a well-established toxicity of the platinum-based chemotherapies that are in frequent use for the
treatment of solid tumors of the head and neck, lung, ovary, testicle, and bladder in adults. Early indicators of
ototoxicity, which could prompt intervention to potentially prevent the health-related and psychosocial impacts
for these patients, are not apparent in the absence of direct auditory measurement. National audiology
guidelines, have stipulated that prospective monitoring for ototoxicity (OM) be conducted for all patients at high
risk for this harmful side effect to allow for early detection, aural rehabilitation, and potential modification of the
drug treatment before the effects become disabling. Specifically, for patients receiving cisplatin, monitoring prior
to each treatment is recommended practice (ASHA 1994; AAA 2009). Based on our current research, OM must
target those patients who will receive the most benefit to be feasible for large-scale implementation in VA.
The goal of this study is to address the critical need in hearing healthcare for improved OM, diagnoses and
clinical interventions in patients receiving treatment with cisplatin, carboplatin, and oxaliplatin chemotherapeutics
by providing new knowledge of the mechanisms of ototoxicity, its functional manifestation, and new insights on
the patient and provider perspective. Our overall approach is to investigate relationships among the specific
behavioral deficits, sites of lesion, and hearing healthcare priorities of chemotherapy patients to learn which
patients will develop ototoxicity, how much damage they can expect, and whether it will impact their everyday
life. This knowledge is needed to shift current OM practice patterns toward a more effective and clinically feasible
approach so that Veterans at elevated risk for ototoxicity could have their auditory concerns addressed through
patient-centered OM, rehabilitation and/or drug therapy interventions. Clinical impacts include estimates of
ototoxicity incidence for Veterans receiving platinum-based chemotherapeutic treatments; and tools to generate
an individual ototoxicity risk profile that when combined with the patient-provider team priorities, will inform OM
resource allocation, pre-treatment counseling, and decision making for ototoxic drug treatment. Knowledge gains
include increased understanding of tinnitus generation and speech understanding deficits and the implications
of these symptoms regarding the underlying ototoxic injury.
To understand more about the mechanisms underlying ototoxicity-caused tinnitus and hearing problems
[Aim 1], we will refine and expand our previously published dose-ototoxicity model and determine its utility for
predicting changes in auditory deficits for individual patients. One refinement will be to include pre-treatment
ABR and DPOAE measures in the model because we expect post-treatment tinnitus and hearing status to be a
function of the combination of any new (ototoxicity-induced) damage with pre-exposure (age and/or noise-
related) damage. Sensory and neural damage will be indirectly estimated using a novel approach that combines
ABRs and DPOAEs (e.g. Bramhall et al. 2017). Neurodegeneration will also be estimated using wideband
acoustic reflex testing, which elicits the reflex to lower stimulus levels than traditional tests, and can be
administered at bedside unlike ABR (Feeney et al. 2017). To determine the clinical impacts of ototoxicity [Aim
2] we will assess the extent to which speech understanding in background noise is compromised following
chemotherapy treatment, using a task that manipulates the temporal cues used for localization (Gallun et al.
2013). Tinnitus and hearing handicap questionnaires will provide knowledge of perceived auditory dysfunction.
Combined information about the clinical impacts and ototoxicity mechanisms will create ototoxicity risk profiles
for individual patients based on their age, planned chemotherapy, and pre-exposure inner ear function. A national
survey of oncologists will be used to review oncology- and OM-related practice patterns in the US.
These results are expected to change current audiological best practice recommendations and are crucial to
advance widespread implementation of OM both within and outside VA.

Public health relevance
Chemotherapy medications can cause tinnitus, hearing loss, and communication deficits – known as ototoxicity – in up to half of Veterans receiving these drugs. Predicting which patients will experience ototoxicity is currently impossible. This is problematic because patients and their doctors generally lack awareness of early indicators of ototoxicity which could prompt intervention to address the subsequent health-related and psychosocial consequences. By examining the auditory injury and the burden of morbidity from ototoxic agents in relation to the perspectives of the patient-oncology team, the proposed research will provide a better understanding of which patients are at high risk for ototoxicity, why they are more susceptible to the damage, and how best to address their ototoxicity through monitoring, rehabilitation, and drug therapy interventions. To further enhance patient-centered oncologic care, this new knowledge will be used to develop tools for forecasting an individual patient's risk for ototoxicity using information obtained prior to treatment.